Transcriptional Regulation by Angiotensin II in Vascular Smooth Muscle Cells

SUMMARY: Vascular smooth muscle cells (VSMCs) in the blood vessel wall play pivotal roles in cardiovascular
disease (CVD; e.g., hypertension), which affects ~48% of US adults, and which is significantly accelerated by
diabetes (DCVD). When stimulated by factors like diabetes and the growth factor Angiotensin II (AngII), mature
VSMCs de-differentiate through “phenotypic switching” (Phe-sw) via dysregulation of "contractile" and "synthetic”
genes, resulting in increased VSMC proliferation, migration, inflammation, and extracellular matrix (ECM)
production. In the previous funding cycles, we unraveled the first functional roles for AngII-regulated long
noncoding RNAs and (super-)enhancers (a key epigenetic regulatory layer) in VSMCs. Our overall objective in
this renewal is to elucidate the mechanisms regulating diabetes- and AngII-induced VSMC Phe-sw at the
epigenome and single-cell (sc) level and how these mechanisms establish vascular metabolic memory (in which
prior hyperglycemia/AngII exposure leads to persistent long-term DCVD despite subsequent glucose
normalization). We will use state-of-the-art multi-omics and sc-sequencing (seq) approaches to decipher VSMC
behavior in DCVD and metabolic memory and identify new drug targets. Our hypothesis is that diabetic
conditions and AngII coordinately re-program the VSMC transcriptome and epigenome, which lead to persistent
dysregulation of genes promoting Phe-sw to unique cellular states underlying VSMC dysfunction and accelerated
DCVD. This hypothesis is supported by extensive new preliminary data that show: i) a diabetic state augments
AngII actions and promotes VSMC proliferation and Phe-sw gene profiles, which persist even after glucose
normalization; ii) DNA methylation is decreased, and chromatin accessibility is increased at key upregulated
ECM and inflammatory genes in VSMCs from diabetic mice, even after culture in normal glucose; iii) new cell
clusters indicative of Phe-sw occur in aortas of Ang II-infused mice, identified using integrated scRNA- and
scATAC-seq; iv) diabetic stimuli induce 3D chromatin changes in vascular cells, seen using chromatin
conformation assays. We will test our hypothesis in 3 specific aims: 1) Define diabetes-induced transcriptomic
and epigenomic changes [AngII-(in)dependent] in VSMCs at Phe-sw-related genes, and the memory of their
persistent dysregulation after glucose normalization in vitro; 2) Elucidate the de-differentiated VSMC subtypes
and their functions in diabetes- and AngII-induced Phe-sw in arteries, and their persistence after glucose
normalization in vivo, using scRNA-seq and scATAC-seq; and 3) Determine the translational potential for
reversing DCVD and vascular memory by targeting candidate genes/loci mediating diabetes- and AngII-induced
VSMC Phe-sw. This innovative study, using cutting-edge technologies and functional in vivo models, will provide
novel insights into VSMC regulatory networks and epigenetic memory of diabetic vasculopathy. This knowledge
has the potential to inform development of much-needed new therapies, especially for patients not responding
well to currently available diabetes drugs and AngII blockers, with far-reaching clinical implications for DCVD.

Public health relevance
Project Narrative Cardiovascular diseases such as hypertension and atherosclerosis are among the major complications of diabetes that are associated with high morbidity and mortality, and therefore significant healthcare problems. This project will use state-of-the-art approaches to identify novel factors and mechanisms involved in the development of diabetic cardiovascular diseases, including those that persist even after glycemic control. The results could uncover much needed newer and better therapeutic targets to curb the development and progression of diabetes induced accelerated cardiovascular diseases, with significant clinical implications.